Leveraging Retained Partner Gene Function to Effectively Target CIC-rearranged Fusion Oncoproteins

Project Summary/Abstract
Gene fusions between the transcriptional repressor Capicua (CIC) and several possible 3’ partner genes,
including DUX4 and NUTM1, drive the progression of aggressive sarcomas with dismal prognoses and few
treatment options. While CIC-fusions are increasingly recognized as a unique clinical entity, to date CIC-DUX4
is the only CIC fusion protein for which any mechanistic research has been published. Even for the limited
available work, the suggested therapies are likely to be limited by a lack of specificity. A failure to understand
the biology underpinning CIC-fused oncoproteins and their signaling pathways hampers the development of
smarter and more effective treatment strategies. Due to the lack of existing research on CIC-fused
oncoproteins, this proposal intends to leverage prior knowledge about the function of individual partner
genes to inform hypotheses about how CIC-fusions function. Wild type CIC is known to be relocalized from
the nucleus to the cytoplasm by FGF- or c-Src-mediated posttranslational mechanisms, and the WT CIC protein
residues thought to be responsible for this shuttling are typically conserved in CIC-DUX4 proteins. Thus, Aim 1
of this proposal tests the hypothesis that FGF- or c-Src signaling can mediate CIC-DUX4 subcellular
relocalization. This will be achieved using a novel EGFP-tagged CIC-DUX4 construct allowing for dynamic
microscopic analysis of CIC-DUX4 localization, as well as using patient-derived cell lines for in vivo modeling. If
this hypothesis is correct, then forced relocalization could be a novel therapeutic strategy. To move beyond the
study of CIC-DUX4, Aim 2 will leverage structure-function studies to define the mechanistic underpinnings of the
means by which CIC-NUTM1 drives tumorigenesis. CIC-NUTM1 is thought to recruit p300 via the NUTM1 moiety
to activate CIC target genes, yet preliminary data suggests this is not the complete story. Thus, Aim 2 will test
the hypothesis that NUTM1 possesses some yet unidentified p300-independent functional domain which
contributes to the activity of the CIC-NUTM1 fusion. These experiments will leverage recently cloned
synthetic, patient-based CIC-NUTM1 fusion plasmids that allow for the first modeling of CIC-NUTM1 tumors.
Uncovering the mechanisms through which CIC-NUTM1 drives tumors will reveal targetable vulnerabilities that
can shape future therapies. Together, the aims will provide foundations for improving treatments and
outcomes in CIC-rearranged tumors. This proposal will be carried out in a world-class environment at UCSF,
which specializes in translational cancer research. The fellowship will provide experimental training in advanced
microscopy and mouse techniques as well as professional development opportunities in areas such as scientific
writing and mentorship which will prepare the fellow for a career as an independent researcher.

Public health relevance
Project Narrative Sarcomas driven by gene fusions between Capicua (CIC) and several partner genes including DUX4 and NUTM1 present as aggressive tumors with dismal outcomes and few treatment options. This project will improve our understanding of the biology underlying these diseases by dissecting how CIC-DUX4 can be relocalized within a cell, and by uncovering the mechanisms CIC-NUTM1 uses to drive tumors. This knowledge will reveal new ways to inactivate the driving causes of CIC-rearranged sarcomas, leading to more effective therapies for an underserved patient population.